Oscillons in Wakefulness and in Sleep: Discrete Structure of Hippocampal Brain Rhythms

ABSTRACT
Neurons in the brain are submerged into oscillating extracellular Local Field Potential (LFP) created by
the synchronized synaptic currents. The dynamics of these oscillations is one of the principal
characteristics of the brain activity at all levels: from the synchronized spiking of the individual neurons
and neuronal ensembles to the high-level cognitive processes.
A physiological interpretation of the LFP data depends on the mathematical and computational
approaches used for its analysis. Traditionally, the oscillatory nature of LFP motivates using Fourier
methods, which have indeed dominated LFP research for the last several decades and currently
constitute the only systematic framework for understanding brain oscillations. Yet these methods are not
well suited for handling two fundamental attributes of biological signals: noise and nonstationarity, and
may therefore obscure the actual physiological structure of the brain rhythms. To address this problem,
we developed an approach based on the Padé Approximation techniques—a powerful novel technique
that allows a much more nuanced analysis of the LFP oscillations.
Previously, our method was successfully applied to studying various physical signals, e.g., to detecting
gravitational waves in gravitational antennas. Applying this method in biological realm also lead us
immediately to new observations. Specifically, we discovered that the hippocampal and the cortical LFPs
recorded in rats consist of a small set of frequency-modulated waves, which we call oscillons. We
hypothesize that oscillons represent the actual, physical structure of the brain waves (such as, e.g., θ-
wave or γ-waves) that was previously obscured by the traditional, less powerful techniques. Another key
feature of our method is that it possesses an impartial marker of the noise component, which allows us
to identify and remove the “noise shell” from the signal and then to investigate not only the noise itself,
but also the interplay between the noise and the oscillatory dynamics.
The goal of the proposed research is to carry and extensive scope of detailed studies of this new level
of the brain rhythms’ structure through this newly discovered computational lens. We anticipate that our
work will lead us a fundamentally better understanding of the brain wave structure in wakefulness and in
sleep, and produce new insights into the underlying neurophysiological and cognitive phenomena.

Public health relevance
PROJECT NARRATIVE Although Local Field Potentials (LFP) are widely used to characterize brain activity at all levels—from the synchronized spiking of individual neurons and neuronal circuit dysfunctions to the high-level cognitive processes, their key attributes—noise and nonstationarity—are handled poorly by standard methods of analyses and therefore our understanding of these phenomena may be obscured. We developed a new technique that handles these attributes much more capably and allows us to refine the traditional understanding of the “brain waves,” e.g., it reveals that the hippocampal and cortical LFPs consist of a few discrete, frequency modulated oscillatory processes—the oscillons—that directly represent the physical structure of neuronal synchronization in these networks. Our goal is to study this new level of structure to gain a better insight into the neurophysiology of wakefulness and sleep.